Project 1: Carolina Breast Cancer Study

Project 1: Carolina Breast Cancer Study (CBCS): Linking Tumor Biology to Social - Abstract
Black women suffer worse stage-specific mortality, in part due to higher relative frequency of late stage,
ER-negative, high grade, and high genomic risk tumors (such as Basal-like and Luminal B tumors), but
mortality differences are also persistent among those with ER+/HER2- disease. Early onset, severity, and poor
survival in Black women’s breast cancer occurs in context of higher risk of multiple conditions, including
obesity, cardiovascular disease, and most recently, deaths due to coronavirus. As such, breast cancer can be
understood as part of a racialized syndemic, a convergence of multiple overlapping chronic and infectious
disease epidemics related to structural racism in the United States. Measures of racial discrimination and racial
animus are strong predictors of mortality but have rarely been linked to breast cancer outcomes specifically.
Previous research has also linked ‘accelerated aging’, ‘premature age’ and ‘biological weathering’ to early
onset of multiple diseases of aging in Black women, but not to breast cancer. Thus, ‘race’ is recognized as
distinct from ancestry-related risk and should be understood in the social context of racism and must be linked
to breast cancer outcomes in that context. Toward this goal, we seek to elucidate the specific, multi-level
influence of racialized social determinants on tumor tissue and treatment patterns and resulting implications for
breast cancer progression and recurrence. Using data from the diverse study population of Carolina Breast
Cancer Study (50% black, 50% younger, 3000+ survivorship cohort), we have previously demonstrated
important tumor biological variation by race. We have found that Black women have higher proliferation scores,
higher risk of recurrence scores, more frequent p53 mutation status, and differential expression of DNA repair,
stromal, and immune response signatures. We have also found that Black women have higher prevalence of
treatment delay as well as different distributions of individual-level social and clinical factors such as quality of
life, education, income, and comorbidities. More recently, we have observed racial differences in CBCS
participant exposure to community-level factors (such as community advantage/disadvantage). Studying each
of these domains individually is important, but joint analysis is needed to identify the most effective health
equity interventions. Under a cells-to-society conceptual model of racialized breast cancer outcomes, we
hypothesize that poor breast cancer outcomes arise due to aggregation of inequities across multiple levels
(biological, individual, community, and structural). In context of race and racism, we propose to evaluate how
inequities in individual (e.g., obesity, comorbidities) and community-level (disadvantage, advantage) exposures
lead to biological (and especially immunologic and DNA repair) differences in tumors (Aim 1). We further
hypothesize that multilevel social determinants alter treatment response and breast cancer recurrence and
survival (Aim 2). Across both aims, our project will use innovative data integration tools to identify novel
intervention targets in precision medicine, extending previous studies of molecular determinants of disparities.

Public health relevance
Project 1: Carolina Breast Cancer Study (CBCS): Linking Tumor Biology to Social - Narrative Black women experience different breast cancer outcomes, with tumor biology, individual exposures, community-level, and structural determinants playing simultaneous roles; effective interventions must be integrative, addressing multi-level determinants in a holistic model. This proposal will evaluate tumor biology in context of a multi-level cells-to-society model to identify predictors of recurrence and survival and to identify novel interventions relevant to precision management of breast cancer.